Specialized pro-resolving lipid mediators and treatment resistant depression

Project Summary/Abstract
Not applicable
This is an administrative supplement to R33 AT012329-01
Rapaport (PI)
04/11/2023 – 03/31/2026
Specialized pro-resolving lipid mediators and treatment resistant depression

Public health relevance
Project Narrative Not applicable This is an administrative supplement to R33 AT012329-01 Rapaport (PI) 04/11/2023 – 03/31/2026 Specialized pro-resolving lipid mediators and treatment resistant depression